A HANDS-FREE LUNG AND CARDIOVASCULAR ASSESSMENT DEVICE (LCAD) FOR THE REMOTE CARE OF PATIENTS WITH CHRONIC CARDIOPULMONARY CONDITIONS

PROJECT SUMMARY
The goal of this project is to develop a remote, hands free self-auscultation and electrocardiogram (EKG)
device for at home use in the remote monitoring and management of patients suffering from chronic
cardiopulmonary conditions. Chronic obstructive pulmonary disease (COPD), congestive heart failure (CHF)
and asthma are the most prevalent chronic cardiopulmonary diseases in this country affecting 4-10%, 1-3%
and 8-19% of the population respectively and they frequently coexist in the same patient. CHF exacerbations is
the leading cause of hospitalizations in people >65 years and COPD exacerbations alone represent the third
leading cause of hospitalizations in the U.S. Acute exacerbations of such chronic conditions that lead to
hospitalizations and death are unpredictable and require immediate diagnosis and treatment to prevent further
decline. Currently in person evaluations with auscultation of lungs, heart and EKG are necessary to confidently
diagnose such acute exacerbations, however they are not available to millions of people due to distance,
transportation, and time constraints. The Covid-19 pandemic has made in-person evaluations unsafe for
patients with chronic conditions. Current hand-held digital stethoscopes with EKG capability are not designed
for telemedicine, too small for elderly and frail patients, are not hands-free for EKG, and do not allow posterior
chest auscultation without a second operator resulting in a health disparity among people who are single or
alone, frail, elderly or have physical disabilities. Development of a hands free, remote self-auscultation and
EKG device for at home use will assist medical providers via telemedicine using real time cardiovascular data
to make accurate diagnoses and deliver evidence based treatment, this can result in halting an exacerbation
and prevent a hospitalization and death. Our team has developed a prototype called Lung and Cardiac
Assessment Device (LCAD) that addresses all of these limitations with promising preliminary data. In this
project, for specific aim 1 we will design and build LCAD’s 4 stethoscope heads, 3 permanent EKG leads,
filtering algorithms, soft shell and perform safety testing. In specific aim 2 we will validate LCAD’s performance
and ease of use in a cohort of 30 normal and diseased subjects as compared to a commercial digital
stethoscope(eko) and gold standard EKG device. We expect 80% agreement on lung sound and
characteristics, EKG quality and characteristics from LCAD’s stethoscope and EKG obtained from the posterior
chest compared to Eko device and gold standard front chest EKG. A SUS score of 80.3 or higher from LCAD is
also expected. In phase II, we will test LCAD’s ability to assist telemedicine clinicians in the remote diagnosis
and management of COPD, CHF and Asthma patients. We expect LCAD to be an important part of the
growing telemedicine- remote patient monitoring market valued at USD 45 billion in 2019, prior to the
pandemic, and expected to witness a 15.1% CAGR from 2020 to 2027.

Public health relevance
NARRATIVE Chronic cardiopulmonary conditions affect 133 million people in the US and lead to 1.7 million deaths annually. Remote cardiopulmonary evaluations can be instrumental in accurate diagnoses and delivering high quality evidence-based treatments. Current available technology is unable to help the nearly 40 million patients suffering from COPD, CHF and asthma that are often frail, elderly and have minor disabilities. In this SBIR, MDDriven will develop a hands-free self-auscultation and EKG device for home use to assist in the telemedical diagnosis and management of patients with chronic cardiopulmonary conditions that can improve patient access to life saving evidence-based treatments utilizing real time cardiopulmonary data.